Methods and Strategies for Concise Syntheses of Intricate Bioactive Compounds

PROJECT SUMMARY, ABSTRACT
This proposal outlines a comprehensive strategy for advancing novel methodologies and innovative strategies
for the chemical synthesis of intricate, bioactive alkaloid natural products derived from Veratrum and
Hapalindole families, among others. The research plan is divided into three distinct projects, each providing
access to unique classes of natural products. Project 1 focuses on the development of novel synthetic
strategies for Veratrum alkaloids, a group of bioactive alkaloid natural products. This project has been inspired
by the structural challenges posed by these alkaloids and aims to develop concise syntheses of several
members. Project 2 details the further exploration of dearomative-Claisen rearrangement, which allows
functionalization of the C2 position of indoles, enabling the stereocontrolled, asymmetric synthesis of 2,2-
disubstituted indoline derivatives. Project 3 outlines our continued study and application of two [4+3]-
cycloaddition-based routes for the synthesis of indole-fused cycloheptanes and their application to the
synthesis of the complex, bioactive ambiguine natural products. The research plan is backed by compelling
preliminary results and aims to maximally utilize the proposed methodology while addressing unmet synthetic
challenges posed by the complex targets. The resulting chemistry is expected to be broadly beneficial to
chemists involved in drug development, chemical synthesis, and natural product research. Over the next five
years, we will especially focus on solving the key structural challenges presented by jervine-type alkaloids
(Veratrum family) and ambiguines (Hapalindole family), providing unique solutions, and recording their
synthesis using methods developed in our laboratory. The proposed projects will provide excellent training to
graduate students and postdoctoral associates in chemical synthesis and problem-solving, preparing them for
successful careers in the pharmaceutical industry and academia.

Public health relevance
PROJECT NARRATIVE This proposal outlines our plans to develop new methods and strategies for the efficient syntheses of structurally complex, bioactive natural products, with a focus on alkaloids from the Veratrum and Hapalindole families that display useful biological properties, including anticancer activity. The work will not only provide efficient access to many natural products and their analogs, but it will also produce chemical synthesis tools for accessing intricate molecules for biomedical studies and pharmaceutical drug development. The challenging nature of these projects will provide graduate students and postdoctoral associates with advanced problem- solving skills and training in sophisticated organic synthesis, equipping them with the knowledge and skills to embark on successful careers in biomedical fields.